CROSS SECTIONAL STUDY OF NUTRITION IN RENAL TRANSPLANT PATIENTS

To assess the nutritional status of renal transplant patients. Nutritional assessment, dietary history and plasma amino acid profile will be determined.